Interrogating Type I Interferon signaling in breast cancer brain metastasis

PROJECT SUMMARY
The brain is one of the common organs for breast cancer recurrence. Breast cancer brain metastasis is
increasingly becoming a significant clinical problem due to its rising incidence and limited efficacy of existing
systemic therapies. Metastasis is the consequence of favorable interactions between the invaded cancer cells
and the microenvironment in the distal organ. To cancer cells, the brain has the most unique
microenvironment since the stromal cells in the brain do not exist in any other organs. This explains why
therapeutic strategies, which efficiently diminish primary and non-brain metastatic breast tumors, are
ineffective in controlling the established brain lesions. Our current work aims to understand the unique brain
metastasis microenvironment and delineate how it facilitates metastatic outgrowth. Type I interferon (IFN)
signaling is a well-recognized anti-tumor pathway. However, experiments from our animal models show that
type I response in astrocytes, the unique brain stromal cells, has a pro-metastatic effect in the brain. Based
on these findings, we will further address the following questions: 1) Define the underlying mechanisms in
how the type I IFN response in astrocytes mediates brain metastasis. We will test the hypothesis that the
activated IFN response in astrocytes helps the recruitment of specific immune cells into the brain lesions. 2)
Validate the type I IFN activation at different stages of brain metastasis. We will apply the top-notch imaging
technique in our mouse models to directly visualize cellular and molecular changes as they occur in real-time,
and validate these observations in clinical samples. 3) Investigate the therapeutic effect of inhibition of
immune cell recruitment on brain metastasis. We will not only identify the druggable targets, but also optimize
the therapeutic windows in our pre-clinical mouse models. Overall, our idea is that once we know how the
brain microenvironment helps cancer growth in the brain, we can focus our efforts on stopping it. Our research
proposal will yield real and actionable targets on brain microenvironment, instead of on cancer cells, to treat
brain metastasis. More importantly, our studies on tracking the dynamic changes during brain metastatic
process will help identify the optimal therapeutic strategies to effectively treat brain metastasis and minimize
potential side effect.

Public health relevance
PROJECT NARRATIVE The brain is one of the common organs for breast cancer recurrence. With rising incidence, breast cancer brain metastasis has become a major problem in clinic. Metastasis is a multi-step process that requires the complex interplay between cancer cells and the stromal cells. In this proposal, we focus on how type I interferon response in astrocytes, the unique stromal cells in the brain microenvironment, facilitates breast cancer brain metastasis. If we define microenvironmental changes during brain metastasis, we can yield real and actionable targets on the brain, instead of on cancer cells, to provide more effective therapies for brain metastasis patients.